Potency and contribution of zebrafish progenitors during innate spinal cord repair

ABSTRACT
Around 18,000 Americans suffer new spinal cord injuries (SCI) each year. Primary and secondary damages
caused by SCI permanently impair sensory and motor functions, which require long-term therapeutic,
rehabilitative, and psychological interventions. Thus, developing therapies to treat or reverse SCI is a pressing
need in regenerative medicine. In contrast to mammals, teleost fish naturally regenerate functional neural tissue
and reverse paralysis after complete spinal cord (SC) transection. Following SCI, pro-regenerative glial and
neuronal responses distinguish the zebrafish SC from the mammalian SC and enable natural repair post-injury.
Importantly, these pro-regenerative processes occur without the detrimental outcomes of reactive gliosis or
neurotoxicity elicited by the mammalian SC. However, little is known about the cellular and molecular
mechanisms that direct glial and neuronal regeneration in zebrafish. In this proposal, we will determine the
potency of the progenitor cells that direct SC repair, and the regenerative roles of neurogenic and gliogenic
progenitor cell types after SCI. These studies will provide a mechanistic understanding of glial and neuronal
regeneration during zebrafish SC repair, and will guide approaches for manipulating SCI outcomes in mammals.

Public health relevance
NARRATIVE Spinal cord injuries are devastating, incurable conditions. Unlike mammals, zebrafish regenerate new neurons and glial cells, and recover swim function after spinal cord injury. Our work will provide in depth understanding of the progenitor cells and molecules that direct these regenerative processes in zebrafish, and will guide approaches for manipulating the burdens to mammalian spinal cord repair.